The role of hypothalamic Slug in the regulation of leptin sensitivity, energy balance, and body weight

Abstract
Recent research highlights pivotal roles of epigenetic reprogramming in health and disease. There is evidence
that epigenetic reprogramming in the hypothalamus is linked to obesity. The hypothalamus encompasses core
neural circuits controlling energy balance, body weight, and metabolic homeostasis. Of note, >95% of known
human obesity-related genes affect brain neural pathways and activities. However, transcription factors and
epigenetic enzymes responsible for epigenetic reprogramming of hypothalamic neurons are unknown. Slug is
a transcriptional repressor and known to promote epithelial-mesenchymal transition in development and cancer
metastasis. Slug binds to E2 boxes via its C-terminal DNA-binding domain, and its N-terminal SNAG domain
binds to EZH2 and HDAC1/2 and recruits the epigenetic enzymes to target promoters/enhancers. EZH2 is the
catalytic subunit of the polycomb repressive complex 2, and catalyzes, in conjunction with EED (a structural
subunit), di- and tri-methylations of histone 3 lysine-27 (H3K27me2/3), repressive epigenetic marks. We found
that Slug is expressed in a subset of hypothalamic neurons and upregulated in obesity. Deletion of Slug in
long-form leptin receptor LepRb-expressing neurons protects against high fat diet (HFD)-induced obesity, type
2 diabetes, and liver steatosis. Likewise, deletion of Slug in the ventromedial hypothalamus (VMH) also
mitigates HFD-induced obesity. Conversely, overexpression of wild-type Slug, but not epigenetic-defective
mutants, in the mediobasal hypothalamus promotes obesity and metabolic disorders. Remarkably, central
injection of EZH2-selective or EED-selective inhibitors ameliorates obesity induced by either Slug
overexpression or HFD feeding. Hypothalamic leptin signaling and brain-derived neurotrophic factor (BDNF)
signaling are known to protect against obesity and metabolic syndromes. We observed that Slug directly binds
to the LepRb promoter and induces H3K27me2/3, thereby suppressing LepRb expression. Slug also
suppresses BDNF expression in the hypothalamus. Based on these findings, we hypothesize that Slug
assembles EZH2/EED epigenetic complexes on the promoters/enhancers of LepRb, BDNF, and other obesity
genes, which deposit H3K27me2/3 to repress the genes. Hypothalamic SLUG/EZH2/EED epigenetic
reprogramming drives the development of obesity and metabolic disorders. We further propose that
pharmacological reversal of the SLUG/EZH2/EED epigenetic reprogramming mitigates obesity and metabolic
disease. We will test these hypotheses in three aims. Aim 1 is to determine whether VMH Slug promotes
obesity by an epigenetic mechanism. Aim 2 is to determine whether EZH2/EED1 complex mediates SLUG’s
pro-obesity action. Aim 3 is to determine whether EZH2 and EED inhibitors mitigate obesity and metabolic
disease by reversing SLUG/EZH2/EED epigenetic reprogramming. The outcomes are expected to establish a
new hypothalamic SLUG/EZH2/EED epigenetic paradigm in the field of obesity and metabolic disease.

Public health relevance
Project Narrative Brain Slug protein controls body weight and metabolism. This project will test a hypothesis that EZH2 and EED, two proteins well-studies for their roles in cancer development, mediate Slug’s pro-obesity action. This project will test the possibility that EZH2 and EED inhibitors, anti-cancer drugs, may be repurposed to treat obesity, type 2 diabetes, and fatty liver disease.